Natural History of Ocular GVHD

All study participants have now completed one year of follow up and many have completed longer follow-up intervals. The data are currently being analyzed. A significant portion of the patients have been advised to use topical cyclosporine eye drops in response to changes in ocular indicators (symptoms, drop in Schirmers tear production, or worsening of surface dryness). We will attempt to identify any correlations between changes in patient symptoms, exam findings, and tear fluid biomarkers. We anticipate completing this analysis in the coming six months.